The POINTER Neurovascular Ancillary Study

PROJECT SUMMARY
Age-related dysfunction of cerebral blood flow regulation plays an important role in the pathophysiology of
brain aging and likely renders the aging brain more susceptible to the damaging effects of comorbid conditions,
such as hypertension, diabetes, and hypercholesterolemia. Impairments in two key mechanisms that regulate
cerebral blood flow at the local and systemic level (i.e., cerebral autoregulation and baroreflex sensitivity,
respectively) may promote cerebral hypoperfusion in the course of normal activities of daily living, thereby
setting the stage for repeated ischemic insults, progressive cognitive decline, and Alzheimer's disease and
related dementias (ADRD). Thus, measuring cerebral autoregulation and baroreflex sensitivity may provide
early biomarkers of neurodegeneration in ADRD studies, particularly those focused on prevention. The U.S.
study to PrOtect brain health through lifestyle INTErvention to Reduce risk (U.S. POINTER) is an ongoing
multi-center randomized clinical trial designed to investigate whether randomization to one of two lifestyle
interventions that differ in format and intensity alters cognitive trajectory over 2 years in 2,000 older adults aged
60-79 years who are cognitively normal but at increased risk for dementia due to first degree family history of
significant memory impairment, sedentary lifestyle, poor diet, and suboptimum cardiometabolic health. The
proposed ancillary study POINTER-NV will comprehensively assess autonomic function, cerebral
autoregulation, and vascular structure and function by evaluating aortic, carotid, and cerebral hemodynamics
using complementary techniques (i.e., ultrasound, tonometry, and continuous blood pressure and heart rate
monitoring) under a variety of conditions (i.e., at rest, during orthostatic stress, and during carbon dioxide
inhalation). These neurovascular outcomes will be assessed at baseline, Year 1, and Year 2 in 500 POINTER
participants across 5 clinical sites (~100 per site; 250 per intervention arm). The primary aim is to assess the
effects of the POINTER lifestyle intervention on cerebral autoregulation and baroreflex sensitivity; we will also
assess intervention effects on aortic stiffness, carotid stiffness, and cerebral vasomotor reactivity. In addition,
POINTER-NV will examine whether these neurovascular outcomes are associated with cognition (assessed
every 6 months as part of the parent trial) and brain structure and function (assessed every 1-2 years as part of
a Brain Imaging ancillary study). By leveraging the rich resources and infrastructure of U.S. POINTER, this
innovative and cost-effective ancillary study presents an unprecedented and time-limited opportunity to expand
the scope and impact of the parent trial and address key research priorities in the field.

Public health relevance
PROJECT NARRATIVE No pharmacologic treatments have been identified to treat Alzheimer's disease (AD); however, lifestyle interventions targeting modifiable AD risk factors provide a promising evidence-based prevention strategy. The proposed study will add comprehensive assessments of cerebral autoregulation, autonomic function, and vascular structure and function in 500 cognitively normal but at-risk older adults enrolled in a multi-site randomized controlled trial involving an intensive 2-year lifestyle intervention to examine intervention effects on neurovascular mechanisms and their association with cognitive and brain outcomes. The results will provide critical insight into preclinical changes that compromise brain perfusion and may identify an effective strategy for improving neurovascular function, which could have important consequences for preventing AD and related dementias.